NK Cell Cytotoxicity Against Cryptococcus neoformans in Persons with Advanced HIV and Cryptococcal Meningitis

PROJECT SUMMARY / ABSTRACT
Cryptococcus neoformans is an opportunistic fungal pathogen that causes localized and disseminated
disease, cryptococcosis, in immunocompromised individuals, such as in people living with HIV. A life-
threatening manifestation of cryptococcosis is cryptococcal meningitis (CM); a central nervous system infection
with acute inflammation of the meninges and the most common cause of meningitis in those with HIV. Sub-
Saharan Africa carries the majority of the global CM disease burden and mortality. Because the host immune
response is crucial to clearance of the infection and resolution of symptoms, a solid understanding of the host
immune response in the state of cryptococcal infection is essential in order to reduce morbidity and mortality.
Natural killer (NK) cells are an innate lymphoid immune cell that has been understudied in CM. NK cells
have antigen independent cytotoxic ability that render them ideal for targeting both intracellular and
extracellular pathogens. This key feature of NK cells could make them an important aspect in the immune
response to C. neoformans, which is both an intracellular and extracellular pathogen. Standard antifungal
therapy targets the pathogen, yet mortality still occurs, including among persons with sterile CSF cultures. My
preliminary data has shown that low CSF concentrations of NK cell cytotoxicity associated soluble molecules
are associated with increased risk of acute 14-day mortality in persons with CM. Therefore, improving NK
cytotoxic activity may be an innovative therapeutic pathway toward reducing cryptococcal mortality.
Additionally, the identification of genes and pathways implicated in impaired NK cell function that could be
modulated to improve cytotoxicity could be targets for future therapeutics.
My central hypothesis is that NK cells contribute to fungal clearance of C. neoformans, but that a
combination of NK cell exhaustion, impaired cytokine production, increased inhibitory receptors, and
decreased activating receptor expression due to the underlying HIV infection disrupts their cytotoxic abilities.
To test the central hypothesis, I am proposing the following Aims: Aim 1 seeks to compare NK cell natural
cytotoxicity and antibody-dependent cell mediated cytotoxicity between HIV-infected persons with CM who die
within 14-days of diagnosis and those who survive >14 day. Aim 2 seeks to determine if persons with CM who
die within 14-days have high levels of differentially expressed genes involved in exhaustion and inhibition of
cytotoxicity pathways when compared to persons who survive CM. Collectively, these findings will provide the
first quantification of NK cell cytotoxicity against clinical isolates of C. neoformans and the identification of
differentially expressed genes associated with acute CM mortality. This information will provide us with specific
genes that are involved in exhaustion, cytokine production, and cytotoxicity that could be modulated in the
future with host targeted immunotherapy.

Public health relevance
PROJECT NARRATIVE Despite advancements in antiretroviral therapy, cryptococcal meningitis continues to be the most common cause of meningitis in persons living with HIV and carries a high mortality rate in low-income countries. The proposed research focuses on quantifying human natural killer cell cytotoxicity against Cryptococcus neoformans and the identification of differentially expressed genes involved in exhaustion, cytokine production, and cytotoxicity. This research could lead to the identification of pathways that can be targeted by immunotherapies to enhance natural killer cell cytotoxicity with the overall goal to increase fungal clearance, reduce morbidity, and reduce mortality from cryptococcal meningitis.